The Role of FEZ Protein Homologs in Early HIV-1 Infection

PROJECT SUMMARY/ABSTRACT
A critical yet still poorly understood step in HIV-1 infection is the early post-entry trafficking of viral cores across
the cytoplasm to reach the nucleus. This requires directed and controlled transport along microtubule filaments
by host motor complexes, but precisely how viral cores control these processes is only beginning to be
defined. This is in part due to the unusual structure of the HIV-1 core, which is a metastable fullerene cone
composed of ∼250 hexamers and 12 pentamers of capsid protein (CA), and its equally unusual and enigmatic
strategies for engaging microtubule motors. Our lab was the first to demonstrate that incoming HIV-1 particles
induce the formation of specialized stable microtubule subsets to facilitate their long-range transport to the
nucleus. We subsequently discovered the first HIV-1-associated cellular motor adaptor, Fasiculation and
Elongation Factor Zeta 1 (FEZ1). Binding to FEZ1 enables viral recruitment and control over the outward-
directed motor, kinesin-1, which often exhibits higher affinities for stable microtubules. Using a variety of
genetic and biochemical approaches combined with live cell imaging of infection in biologically relevant cell
types, our data further revealed that localized phosphorylation of FEZ1 on viral cores allows HIV-1 to regulate
kinesin-1 activity. This in turn controls the bi-directional movement of virus particles, a key process that allows
cargos to navigate the densely crowded cytosol while ultimately favoring net forward displacement to reach the
nucleus. While FEZ1 phosphorylation enables viral control over Kinesin-1, our data now demonstrates that
distinct coiled coil (CC) domains in FEZ1 mediate its binding to viral capsids through high avidity charge-based
recognition of hexamer pores, yet the exact structural basis of these interactions and their functional roles in
infection remain unknown. Preliminary data further shows that each of FEZ1’s four CC domains play a role in
infection. Based on structure modeling using AlphaFold3, we hypothesize that CC2 and CC4 mediate binding
to capsids while CC1 and CC3 regulate kinesin-1 engagement. Additional preliminary data further reveals that
FEZ2 is a structurally and functionally divergent paralog of FEZ1. Structural comparisons suggest that FEZ2
contains distinct CC domain organizations that still mediate interactions with HIV-1 capsids but lacks kinesin-
regulatory domains. In line with this, we find that FEZ2 inhibits HIV-1 trafficking to the nucleus and the
establishment of infection. Furthermore, our data demonstrate that FEZ2 is differentially expressed relative to
FEZ1 in different biologically relevant cell types. From these data, we hypothesize that divergence in their CC
domains underlies the distinct pro- and anti-viral activities of FEZ1 and FEZ2 proteins, respectively, and their
relative expression levels serve as an important determinant of cellular susceptibility to infection. Developing a
detailed structural and functional understanding of how FEZ family members interplay and exert opposing
effects on infection will not only provide fundamental insights into poorly understood aspects of HIV-1 infection
but may also guide the future development of targeted antivirals that disrupt these capsid-based interactions.

Public health relevance
PROJECT NARRATIVE Several aspects of HIV-1 infection remain poorly understood, including how viral cores traffic to the nucleus after entry into the cytosol. Our preliminary data reveals that the cellular protein FEZ1 serves as a high-avidity kinesin motor adaptor for HIV-1 yet its paralog, FEZ2 is a structurally divergent antagonist of FEZ1 and an inhibitor of infection. Using an array of biochemical, structural and functional approaches, this project will determine how these novel pro- and anti-viral members of the FEZ protein family interplay to determine cellular susceptibility to infection, an understanding of which may ultiamtely guide the design of future antivirals that target these capsid-based interactions.